Determining the Impact of Edelfosine on Restoring the Gut Microbiota after and Epileptic Insult

ABSTRACT
Determining the impact of edelfosine on restoring the gut microbiota after an epileptic insult
Most anti-epileptic therapies induce significant side effects [1-3], emphasizing the critical need to explore
new strategies to treat epilepsy. Recent research indicates a correlation between dysbiosis and central
nervous system (CNS) in epilepsy [4,5]. Modulating the gut microbiota in epilepsy patients through
probiotics, diet, or fecal matter transplant (FMT) has shown positive effects in patients with epilepsy [6].
Given the role of phospholipase C (PLC) in mediating inflammatory modulation and cytokine production
in T-cells and macrophages [7-9], the use of PLC inhibition as an anti-inflammatory strategy is another
promising strategy to reduce epileptic seizures. The proposed aims will use edelfosine (Ef),
encapsulated in a drug delivery system (DDS), as a PLCβ3 inhibitor [10-12] This project explores whether
Ef impacts the gut microbiota and metabolites following an epileptic insult. We will collect fecal matter of
naïve animals and epilepsy-induced animals before and after the seizure (2h, 26h, 50h) and analyze gut
microbiota, its metabolites, and brain metabolites. We will compare the obtained data in Ef-treated and
untreated mice.We hypothesize that Ef will promote an anti-inflammatory microenvironment within the
gut by protecting the survival of butyrate-producing taxa such as Bifidobacteria and Lactobacillus after
an epileptic insult.
The Center for Microbiome Studies (CMS) 16S sequencing and metabolomic cores and mentoring to
delve into this new field will be essential to accomplish the proposed 3 aims: 1) Characterize the gut
microbiome in an animal model of epilepsy and associate its α- and β-diversity with the effect of Ef. We
will compare 16S rRNA sequencing of feces collected before and after an epileptic insult in Ef treated
and untreated mice. 2) Identify differences in gut bacterial and brain metabolites associated with lower
inflammatory status in Ef-treated versus untreated mice, using GC/MS and LC/MS-based metabolomics
in the fecal samples and mouse brains of Aim 1 mice. 3) Characterize if FMTs from Ef-treated mice can
increase gut resilience in animals with epilepsy, reducing the severity of seizures. FMT from Ef treated
and untreated mice will be gastrointestinally gavaged into naïve mice and 24h later, we will measure and
compare seizure activity. Fecal microbiota and metabolomics of feces collected before and after the
seizure (2h, 26h, 50h) will be compared. The Center for Microbiome Studies will enable me to
generate the data for these 16S sequencing and metabolomic studies, allowing my research area
to expand in an innovative direction toward dissecting how specific treatments could impact the
gut-brain axis. This center will allow me to build new skills, recruit students to develop their
projects, and establish expertise in new areas, strengthening the laboratory's capabilities.

Public health relevance
Project Narrative These studies will advance our fundamental knowledge of the communication between the brain and the gut under epilepsy-like conditions. They aim to clarify the effects of a drug called edelfosine, on various aspects after an epileptic insult, including the composition of gut microbes, communication between the gut and brain via metabolites, and the influence on immune cells and inflammation via cytokines. Studying the effect of drugs on the gut-microbiome following an epileptic insult, is in line with our long-term objective of comprehending gut-brain interactions post-drug treatment, fostering innovative therapeutic approaches with fewer side effects for patients.